The University of Iowa Clinical and Translational Science Award

INSTITUTIONAL CAREER DEVELOPMENT CORE (KL2)
ABSTRACT
This is a NEW application for an Institutional Career Development Core in the University of Iowa CTSA.
This Core will be the home for four KL2 Scholars as well as 20-30 additional K awardees across the Colleges
of Arts & Sciences, Dentistry, Engineering, Medicine, Nursing, Pharmacy and Public Health. A diverse group of
KL2 Scholars will be recruited from current and incoming junior faculty whose primary career goals focus on
the pursuit of clinical and translational research in health related fields. KL2 Scholars will be supported for
three years with the goal of each Scholar obtaining individual K or R funding during this experience.
The Institutional Career Development Core will take full advantage of the entire spectrum of support
services, faculty and staff in the Institute for Clinical and Translational Sciences (ICTS), the University, and the
health care facilities under UI Health Care umbrella and the state. Our faculty and mentors have a breadth of
expertise in 1) patient centered outcomes research, 2) preventive medicine research and practice, 3) health
outcomes databases, 4) medical engineering and economics, 5) design and conduct of clinical trials, and 6)
introduction of pharmaceutical discoveries to practice. The KL2 program will rely on the Translational
Biomedicine training program housed in the Workforce Development Core of the ICTS to provide state of the
art didactic theory and skill training in all aspects of the 14 major competencies, enabling individualized career
development. All Scholars will participate in K Club which emphasizes peer mentoring and scientific
communication. Additional KL2 activities afford Scholars the opportunity to participate in team science and
externships in industry as well as in governmental agencies.
Development and completion of a mentored research project is at the heart of Iowa's Institutional Career
Development Core. Each KL2 Scholar will be matched with a primary mentor and together they will train in the
Iowa Mentoring Academy, a university-wide endeavor housed in the CTSA and based on the National
Research Mentoring Network platform. The formalized mentor and Scholar training will include evaluation of
outcomes in terms of Scholar research and publication quality, independent funding, and retention of Scholars
in translational science careers. We will strive to achieve these outcomes through three specific objectives:
1. Recruit and train outstanding scholars from diverse scientific and racial/ethnic backgrounds who will
engage in an individualized curriculum and in mentored health care research during a three-year period
in a KL2 program.
2. Enhance the mentoring environment for translational research scholars through a robust program for
both mentors and mentees built on the National Research Mentoring Network training platform and
3. Provide a highly focused mentored research experience that fosters scholars' successful transition to
independence and continued engagement as leaders of translational health care teams.